Personalizing Outcomes of Nephrolithiasis in Youth (PONY) Administrative Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The central mission of the proposed Personalizing Outcomes of Nephrolithiasis in Youth (PONY) P20 Center
is to generate knowledge that improves outcomes for youth with nephrolithiasis though collaborative research
among established and Early-Stage Investigators. To achieve this mission, this proposal strengthens
partnerships among Children’s Hospital of Philadelphia, Children’s Wisconsin, and Lurie Children’s Hospital of
Chicago. The Administrative Core will draw upon the resources of each institution, the robust infrastructure of
the Pediatric KIDney Stone Care Improvement Network (PKIDS), the perspectives of the Kidney Stone
Engagement Core, and data generated by the NIDDK-supported Urinary Stone Disease Research Network
(USDRN) to overcome structural barriers that have impeded the generation of impactful new knowledge and
have prevented the entrance and continued success of new investigators into benign urologic research.
In the proposed PONY P20 Center, we address critical structural and scientific barriers that have impeded
strengthening the evidence base for management of pediatric nephrolithiasis. The Administrative Core will
provide the project management support to ensure the success of the proposal. This support includes providing
resources and infrastructure to complete the Research Project and facilitating the continued trajectory of Early-
Stage Investigators towards future independent R01 funding. Aim 1 of the Administrative Core is to support the
Research Project. The Administrative Core will create opportunities for Drs. Ellison and Chu to lead the execution
of the Research Project through operational and logistical support as well as data access. Aim 2 of the
Administrative Core is to accelerate the research careers of Early-Stage Investigators and enhance the clinical
impact of their research. The Administrative Core will integrate the research project into the existing
organizational structure, relationships, and resources of PKIDS, which includes 30 institutions in North America.
The Administrative Core will actively disseminate the results of the Research Project and promote their
implementation into clinical care throughout PKIDS, thereby expediting and enhancing the impact of these
findings. PKIDS will also provide the scientific environment to support the R01 applications led by Drs. Ellison
and Chu that will arise from the Research Project. Aim 3 of the Administrative Core is to disseminate knowledge
generated by the PONY P20 Center to the CAIRIBU community and the broader research base. The
Administrative Core will access bidirectional channels created by the U54 Interactions Core to share and receive
new ideas and knowledge with the CAIRIBU community and the broader benign urologic research base. Overall,
the Administrative Core will facilitate the generation of knowledge that addresses critical priorities identified by
youth with nephrolithiasis and will accelerate the career of early-stage investigators who will be leaders in benign
urological research.